Understanding How Children with Hemiparetic Cerebral Palsy Anticipate Gait

PROJECT SUMMARY/ABSTRACT
Of all children in the US born with Cerebral Palsy (CP), 30-40% of them will be diagnosed with Hemiparetic CP
(HCP), presenting with one side of the body being weaker than the other. The resulting asymmetries impede the
ability of children with HCP to distribute weight evenly between their lower limbs. This, often, contributes to poor
postural control and `favoring' of their uninvolved side (increased load on the uninvolved leg) during balance and
gait. While many studies have examined gait and balance, our project serves as a foundational first step toward
understanding how gait and balance influence one another.
We're proposing a prospective, 40 participant (20 children with HCP and 20 typically developing (TD)
children) one-visit study to locate and track the center of pressure (COP) during standing and walking tasks. This
work seeks to determine the impact of gait anticipation (GA, i.e., expectation of initiating a step) on balance and
load symmetry during quiet standing for children with HCP in comparison to TD peers. This aim allows us to fill
the gap in knowledge concerning the relationship between GA and quiet standing balance. Completion of this
will define for the first time the impact of load symmetry on balance for children with HCP.
This work will also determine the impact of changing stance limb (dominant/non-dominant) on COP
displacement and reaction time during gait initiation (GI) in children with HCP when compared with TD peers.
While there is a clear difference in ability between limbs (especially for children with HCP), no one has
attempted to quantify or comparatively analyze these differences. Assessing the ability of each limb to be
the leading limb during GI provides a framework for evaluating how each limb performs when completing other
daily activities, such as climbing stairs or stepping over obstacles. We can apply our findings toward revealing
rehabilitation targets that not only focus on strengthening the more involved side, but also improve bilateral
ability.

Public health relevance
PROJECT NARRATIVE Hemiparetic Cerebral Palsy (HCP) results in an uneven displacement of weight between the legs, which has been noted to impact everything from balance to gait and activities of daily life, including stair climbing and stepping over obstacles. For the first time, using novel approaches, asymmetrical limb loading will serve as a measure to connect standing balance adjustments to a child's ability to effectively initiate gait whether the child has HCP or is typically developing. Supported by a diverse team of experts in biomechanics, pediatric rehabilitation, biostatistics and human factors, this project seeks to provide quantitatively robust and impartial results that will improve health outcomes for children with HCP and build a bridge for collaboration and innovation in the future.